SUPPORT SERVICES FOR THE PLCO ETIOLOGIC & EARLY MARKER STUDIES(PLCO EEMS)

Perform services that support all aspects of the PLCO EEMS program administration, including system administration, web hosting, peer review logistics and tracking, sample requisition, and progress monitoring of the approved studies.